IFG::OT::IFG: Care, Use and Welfare of Marmosets as Animal Models

This request is for partial support of the workshop: Care, Use and welfare of Marmosets as Animal models fore Gene-editing based Biomedical Research